Improving transfusion therapy for patients with sickle cell disease with pluripotent stem cell-derived red cells

ABSTRACT: OVERALL
Red blood cell transfusion remains a life-saving therapy for patients with sickle cell disease (SCD). A major
problem is the high rate of alloimmunization (antibody formation against transfused red cells) that occurs in
transfused patients with SCD. Genetic diversity in blood group antigens in patients of African descent
compared to the primarily European-based donor pool contributes to this high incidence and complexity of
antibodies found in patients with SCD. Finding compatible red blood cell (RBC) units is often complicated by a
lack of rare reagent RBCs to properly identify these complex antibody specificities. This complication delays
care, increases costs, and makes transfusion therapy impossible for some patients. The ultimate goal of this
proposal is to use human induced pluripotent stem cells (iPSCs) to produce standard and reliable red blood
cell (RBC) reagents to resolve this major problem. We have designed a panel of iPSCs genetically engineered
to express unique combinations of blood group antigens (customized iPSCs) that are difficult or virtually
impossible to find in donor RBCs. RBC reagents produced from these customized iPSCs will provide the
means to streamline and standardize antibody identification in alloimmunized patients, and ultimately can be
used as “universal” donor cells for future therapeutic applications. Our efforts will address several existing
challenges that include: i. insufficient or no living blood donors expressing the combinations of blood group
antigens needed to resolve the complex antibody specificities in patients with SCD, ii. lack of iPSC
differentiation protocols to produce definitive, adult-type RBCs without the use of serum or stromal cells, and iii.
the prohibitively expensive manufacturing costs of iPSC-derived RBCs. In this U01 application, we propose
three integrated Projects from a group of highly collaborative investigators with expertise in areas that can
address all three challenges and will drive the field forward by providing innovative solutions to these current
obstacles.

Public health relevance
NARRATIVE The overall theme of this grant is to develop a strategy for generating human pluripotent stem cell-derived red cell reagents to improve antibody identification and donor selection for transfused patients with sickle cell disease. We present three overlapping Projects with innovative solutions to major challenges that have been identified in the field. We also present an overall plan to synergize these Projects, enabling them to coordinate as a team, to use uniform cell lines and technologies, and to perform standardized blood bank assays to test laboratory generated red cell reagents that should support reaching a successful outcome.